Dynamic Nanofibrous Hydrogels for Enhancing Stem Cells' Therapeutic Potency

Project Summary/Abstract
Human mesenchymal stem cells (hMSCs) are considered a source for allogeneic therapies to treat
diverse diseases. Due to the exponential increase in demand, there is a need for new strategies to produce
potent hMSCs to serve diverse patient populations. Currently, conventional planar culture and bioreactors are
used as scale-up manufacturing methods. However, these are not specifically tailored for hMSCs expansion.
They may alter the cell phenotype and secretome, affecting clinical effectiveness. Further studies to understand
the role of substrate mechanics on hMSC expansion are required to achieve reproducible production. Numerous
scaffolding alternatives replicate several characteristics of the native extracellular matrix (ECM). However, its
dynamic mechanics, which plays a fundamental role in regulating crucial cellular processes, has not been amply
studied yet. Furthermore, most in-vitro substrates are static and supraphysiologically stiff. Static substrates have
offered a substantial benefit for generating high cell numbers; however, hMSCs have been shown to retain
mechanical information, limiting therapeutic capabilities. To address this problem, this proposed research seeks
to investigate the role of dynamic cell-matrix interactions and nano-topographical cues on the immunomodulatory
potential of hMSCs using a composite of electrospun-fibers encapsulated in a dynamic hydrogel, with the
hypothesis that this composite biomaterial will promote high hMSCs production with relevant therapeutic value,
while eliminating the limitations reported for the conventional cell culture systems. The K99 period will focus on
engineering and characterizing the dynamic nanofibrous hydrogel composites to propel me toward establishing
the mechanisms by which they modulate cell quality and potency attributes with relevant therapeutic value
(during the R00 phase). In Aim 1, we will develop the dynamic nanofibrous system using a hyaluronic acid
hydrogel network crosslinked via dynamic covalent hydrazone bonds that capture the viscoelasticity of ECM in
tissues. Four variables, including the encapsulation of the electrospun collagen nanofibers at various densities,
fiber diameter, fiber length, and the stress relaxation timescale of the hydrogel will be characterized in this aim
to promote hMSC viability and proliferation. In Aim 2, hMSCs cell quality and potency will be assessed by
measuring the effect of hydrogel parameters on cellular secretory activity. Immunomodulatory properties will be
evaluated by quantifying lymphocyte suppression in co-culture, as well as expression of hMSC surface markers.
The capacity of the hMSCs to differentiate will also be assessed. In aim 3, the mechanism linking the biophysical
parameters of the nanofibrous hydrogel to hMSC secretory activity will be probed by examining cell adhesive
proteins and the activation of transcription factors or sensors of mechanical cues. In sum, the proposed research
will lead to new insights to produce hMSCs with high therapeutic value, which will enable new culture substrates
that achieve control in reproducibility and cell quality to serve diverse patient populations.

Public health relevance
Project Narrative The use of hMSCs to treat diverse diseases has recently shown an exponential increase in demand; therefore, it could become a big problem if the cell manufacturing field cannot accommodate the production line to supply future needs. Currently, many of the static in-vitro substrates, conventional culture, and bioreactors systems have offered a substantial benefit for generating high cell numbers, but with limited therapeutic capabilities. This proposal aims to address that limitation by designing a dynamic composite of electrospun- fibers encapsulated in a hydrogel that replicate the dynamic mechanics and topographical structure of native ECM toward high hMSCs production with relevant therapeutic value.